NC State Molecular Biotechnology Training Program (MBTP)

Training in molecular biotechnology is essential for an expanding list of science and engineering disciplines where modern biology‐based skills are critically important in pursuing research goals. To address this, NC State University has created a core education facility that serves campus‐wide needs for graduate students requiring laboratory‐based training in aspects of modern biology. This not only facilitates the students’ dissertation research, but also lays the basis for career opportunities in academic, government, and industrial settings. Using this campus educational resource as a framework, NC State University proposes to continue and enhance a Molecular Biotechnology Training Program (MBTP) to foster graduate level training for students from at least 5 colleges and 13 university departments/programs. An Executive Committee chaired by the Directors will lead the operation of the MBTP and oversee sub-committees focusing on program elements. The specific objectives of the training program are: 1) ensure technical proficiency and training in responsible and rigorous science; 2) provide an educational and professional experience that satisfies graduates’ expectations; 3) foster robust PhD graduation and career outcomes. Ten trainee slots are requested that will be augmented by four slots funded from university resources. The program requirements include: a graduate-level laboratory minor in Molecular Biotechnology; an off‐campus, 3-month industrial internship; a capstone biotechnology design course; a course in professional development; courses in research ethics; a course in scientific rigor and reproducibility; an annual research symposium; and a biotechnology‐related outreach project. These requirements are in addition to those associated with the student’s particular department or program for the doctoral degree. Most MBTP trainees complete their program in the second and third year of their doctorate, but the program is flexible to accommodate students’ interests and experiences. This program also provides a central focus for faculty of the various disciplines involved in this training effort to seek out new opportunities for formal and informal research collaboration.

Public health relevance
Advanced training in molecular biotechnology is critical to modern biomedical science research and should be a key component of pre-doctoral education for students aspiring to academic, industrial, and government research careers. This Molecular Biotechnology Training Program at NC State University provides trainees from a wide range of graduate disciplines access to cutting-edge biotechnology training, complemented by an appreciation of responsible conduct of research and scientific rigor and reproducibility. Furthermore, students will be given opportunities for professional development through a variety of mechanisms, including workshops and internships.